Strengthening HIV Oral Health Human Resource for Research Capacity in Uganda.

Abstract
Globally, oral diseases represent a neglected area of research in both the public health and global health
discourse. Oral diseases are largely preventable and treatable, yet affect approximately 3.5 billion people
globally, increasing health and economic burdens while significantly decreasing quality of life. The
populations in low- and middle-income countries (LMICs) are disproportionately affected by oral diseases
highlighting the widespread poverty and inequalities experienced by those least able to access care. Sub
Saharan Africa (SSA) bears 24% of the world’s total burden of infectious diseases that include 69% of the
global HIV disease burden. The oral cavity has played an important role in guiding the management of HIV
based on the effects of HIV on the oral cavity. In LMICs like Uganda there is a need for more efforts to
understand the co-morbidities during long-term Anti-Retroviral Treatments and non-AIDS defining illnesses
that are emerging as significant contributors to morbidity and mortality among adults aging with HIV
disease more so in relation to the oral cavity, the focus of this application. The overall objective of the work
that is proposed in this application is to strengthen the oral health research capacity in Uganda. This work
builds on NIH grants at Makerere University and Uganda Christian University that include the two led by the
PDs (Grant Number: 1R56DE032217, PD Buwembo William, Grant number: 4UH3HL154501, PD Semitala
Fred). The team will work to achieve the overall objective through the following aims: Aim 1: To determine
the current research training needs for HIV oral health personnel in Uganda. Aim 2: To mobilize research
training resources and partners for HIV related oral health research. Aim 3: To prepare a D43 training grant
application to address the identified gaps in Ugandan HIV related oral health research. This effort takes
advantage of the access to large numbers of patients living with HIV and the multi-disciplinary/inter
professional education expertise at MakCHS to increase the oral health research capacity in Uganda. Our
immediate goal is to develop a follow up D43 training program that will support the strengthening of oral
health research through a high-quality oral health research portfolio based on the work of an initial critical
mass of local research scientists. This will align our efforts with those of NIH OAR with regards to research
training of the multidisciplinary workforce required to conduct High Priority HIV/AIDS or HIV/AIDS-related
research.

Public health relevance
Narrative Oral diseases affect approximately 3.5 billion people globally, increasing health and economic burdens while significantly decreasing quality of life. This is especially true in sub-Saharan Africa where this burden is made worse by HIV. In this application, whose overall objective is to strengthen the oral health research capacity in Uganda, the team will work through the proposed aims to plan for the establishment of an oral health research training program for Makerere University and Uganda Christian University, that is well aligned to the NIH HIV AIDS priority area on research training of the multidisciplinary workforce required to conduct High Priority HIV/AIDS or HIV/AIDS-related research.